Investigational Cancer Therapeutics Training Program (ICTTP)

PROJECT SUMMARY/ABSTRACT
The goal of the T32 Investigational Cancer Therapeutics Training Program (ICTTP) at Memorial Sloan-
Kettering Cancer Center (MSK) is to provide highly select physician trainees in hematology and medical
oncology with the research training necessary for successful careers in the translation of cancer biology
discoveries into novel molecular, immune, or cell-based therapeutics, and those experimental treatments into
clinical trials that have the potential to change standards of care. The T32 ICTTP program accomplishes this
goal by combining a comprehensive mentored training program, an extensive didactic curriculum in clinical and
translational research methodologies, and experiential programs supporting development of the critical career
skills (e.g. collaboration, research management, grant writing) necessary for academic success. Each year, we
select 4 highly committed postdoctoral trainees from the pool of outstanding physicians at MSK who have
completed at least 3–4 years of both internal medicine and oncology/hematology clinical training. T32 trainees
are then supported for 2 consecutive years so that ≥ 80% of their time and effort is dedicated to research
training. Based on individual research interests and career goals, ICTTP trainees develop either a laboratory-
based or a prospective clinical research program with guidance from their mentors, who are established,
independently funded investigators. These programs involve extensive collaborative scientific interactions,
including additional clinical scientist mentorship for laboratory-based trainees and laboratory scientist
mentorship for clinical research trainees. The T32 ICTTP supplements mentored research training with a
curriculum of symposia, workshops, in-person didactic programs, and online courses that prepares trainees to
conduct successful, independently supported research at the faculty level. We continue to enhance the
program by revising and adding new educational programs in clinical research methodology, research ethics,
national and international clinical trial requirements and conduct, as well as hands-on writing workshops for
grants and protocols. Participating faculty mentors are continually reviewed and selected based on strict
criteria for research productivity, independent funding, and quality of mentoring. T32 ICTTP mentors have
research programs on cancer genetics, genomics, epigenetics, signal transduction, and metabolism; tumor
immunology and immunotherapy; drug and cellular therapeutic development; and tumor evolution, using
systems and computational approaches. Projects conducted by T32 ICTTP trainees in the proposed funding
period continue similar themes in cancer therapeutics research. All T32 ICTTP graduates from the last funding
cycle are continuing in faculty or pharmaceutical industry positions in cancer research, with the majority having
secured independent research funding. This success continues the ICTTP's 40-year track record of training
leaders in cancer therapeutic development and translational research.

Public health relevance
PROJECT SUMMARY/ABSTRACT Accelerating the future development of new cancer treatments requires educating the next generation of leaders in this field in the complex interactions between tumors, their surroundings, and the immune system, and preparing them to efficiently conduct research in today's regulatory and administrative environment. The T32 Investigational Cancer Therapeutics Training Program (ICTTP) at Memorial Sloan Kettering Cancer Center addresses this need by providing fellows in medical oncology who are committed to careers in translational cancer research with comprehensive mentored research and didactic training for two years. The ICTTP program is designed to optimally train physician scientists to translate discoveries regarding the biology of cancer into new, approved molecular/cytotoxic, immunotherapeutic, and cell-based treatments through state-of-the-art experimental trials.